Orthogonal split luciferases for imaging multiplexed cellular behaviors

PROJECT SUMMARY
Disease states are characterized by complex interactions that occur between a variety of cell types and
biomolecules in an organism. Researchers have turned to bioluminescence imaging (BLI) to track the
behavior of these cells and understand the underpinnings of disease and the development of effective
treatments. BLI utilizes the light-emitting ability of bioluminescent enzymes to sensitively illuminate
individual cells without the need for surgery. Because organisms do not glow, BLI is exquisitely sensitive,
with the ability to detect as few as one glowing cell in the body of a mouse. This has enabled researchers
to study the efﬁcacy of cancer-killing drugs, the location and progression of infection, and the success of
stem cell treatments. Despite its ubiquity in the ﬁeld, BLI of multiple different cell types simultaneously
remains difﬁcult. Our research seeks to further expand the utility of this tool through a unique approach to
multicomponent bioluminescence imaging. To accomplish this, we will repurpose a split bioluminescent
protein called NanoBiT. NanoBiT comprises a heterodimer binding pair made up of a small peptide, called
SmBiT, and a larger protein subunit, called LgBiT. NanoBiT is only capable of light emission when SmBiT
and LgBiT bind. In Aim 1 of the proposal, we will use protein engineering and directed evolution techniques
to produce orthogonal SmBiT-LgBiT binding pairs. Libraries of LgBiT enzymes will be cloned, and a panel
of SmBiT peptides will be synthesized. High-throughput techniques will evaluate the light emission of each
LgBiT mutant in combination with each SmBiT peptide. "Winning" mutants will be sequenced via next
generation sequencing (NGS) and mutations will be combined to form optimized orthogonal probes. In Aim
2 we will test our new orthogonal NanoBiT probes in mammalian cells, tissue models, and in the bodies of
live mice. First, to improve the tissue penetration of NanoBit light emission, we will modulate the color of
bioluminescence by appending small molecule ﬂuorophores to our SmBiT peptides. Stable mammalian
cell lines containing our probes will next be tested with our SmBiT-ﬂuorophore probes in tissue models and
in live mice. Probes will be judged by their sensitivity and selectivity. This work will represent the ﬁrst effort
to adapt NanoBiT for multicomponent imaging. Our protein engineering data will be immediately useful to
the bioluminescence imaging community. Further, these probes will be useful for imaging protein-protein,
host-pathogen, and cancer-immune cell interactions.

Public health relevance
PROJECT NARRATIVE Disease progression is characterized by a complex interplay of a variety of cell types in living organisms. The ability to "see" these interactions is crucial for understanding the causes and potential treatments of illness. We are developing bioluminescent proteins that will illuminate multiple cell types at the same time in the body of a mouse to study such interactions.